Intraoperative Nerve Damage Assessment Using Nerve-Specific Fluorescence Guided Surgery

PROJECT SUMMARY
Acute peripheral nerve crush injuries frequently result from closed or open fractures, joint dislocations, and high-
energy collisions. Nerve crush, stretch, or transection can lead to functional deficits ranging from numbness to
complete motor and sensory function loss, affecting ~1.6M trauma patients annually. Assessment of the degree
of injury and the possibility for functional recovery after injury remains challenging and intraoperative nerve
stimulation, the only methodology to aid in decision-making during nerve repair surgery, often yields minimally
useful information. Thus, surgeons are left to make nerve damage assessments via gross visual examination,
which fails to capture the degree of axonal disruption, leaving ~50% of patients with poor functional recovery
outcomes. Surgeons and patients would benefit from a rapid intraoperative assessment of nerve damage to
make informed treatment decisions. We hypothesize that fluorescence imaging using a novel nerve-
specific fluorophore could provide an objective methodology to determine the degree and recoverability
of nerve injury, guiding surgical intervention in real-time to improve patient outcomes following
orthopaedic trauma surgery. We have developed a library of first-in-kind, targeted, near-infrared (NIR)
fluorophores that label nerve tissue with high affinity and are currently undergoing preclinical pharmacology and
toxicology testing to facilitate first-in-human (FIH) trials for improved intraoperative nerve visualization. These
fluorophores provide nerve visualization with high contrast at millimeter to centimeter tissue depths in mice, rats,
and swine and preliminary studies show clear identification between healthy and injured nerve tissues following
topical or systemic administration. Herein, we propose to fully characterize the fluorescent uptake profiles and
intensity differences between healthy and damaged nerve tissue using our NIR nerve-specific fluorophores to
provide an objective methodology for intraoperative nerve damage assessment. This study’s immediate
milestones will include (1) selection of an administration time point for the developed methodology, (2)
quantification of fluorescence intensity (FI) and uptake parameters in healthy, permanently damaged, and
recovering nerve tissue in mouse sciatic nerve injury models and (3) validation of the developed nerve damage
assessment methodology in a blinded rat sciatic nerve injury study for future clinical translation. Completion of
the proposed aims will result in the first objective nerve damage assessment methodology for trauma surgery
utilizing novel NIR nerve-specific fluorophores developed by Inherent Targeting. The proposed studies will
provide proof-of-concept for the expanded utility of our novel probe for future clinical translation, enabling a
robust diagnostic assessment for patients. This work will build upon work underway to obtain clinical approval
for these novel nerve-specific probes and provide a strong foundation as a platform technology for intraoperative
guidance. In Phase II of this project, FIH trials will be completed for the developed nerve damage assessment
methodology to validate translation to trauma patients undergoing reparative surgery.

Public health relevance
PROJECT NARRATIVE Acute peripheral nerve crush injuries are the common result from closed or open fractures, joint dislocations, and high-energy collisions, which can lead to functional deficits ranging from numbness to complete motor and sensory function loss. Assessment of the degree of injury and the possibility for functional reconstruction remains challenging and to date no reliable methodology exists to aid in decision-making during orthopaedic trauma surgery. In the proposed studies, we will develop a nerve damage assessment methodology using our novel near-infrared nerve-specific fluorophores for fluorescence guided surgery to facilitate objective assessment of the degree of nerve injury and the potential for recovery to guide trauma surgery for complex peripheral nerve injuries.